Building the Science of Evidence-Informed Prevention Policy: A Multi-level Model for Supporting Substance Misuse Prevention

Project Summary
If science is to inform policy and ultimately improve public health, the field needs an effective strategy for directly
supporting policymakers’ use of research evidence. However, our field lacks an evidence-based model designed
for supporting state policymakers’ use of prevention research in crafting legislation. Instead, we continue to
largely rely on ad hoc strategies for translating prevention research (e.g., opportunistic outreach and responding
to policymakers’ requests if or when they are made). Accordingly, we propose an experimental study of a formal,
theory-based approach for supporting policymakers’ use of scientific evidence that does not involve lobbying—
the Research-to-Policy Collaboration (RPC) Model. The RPC fosters productive engagement between the policy
and research communities by implementing systematic capacity building and outreach strategies. Previous
experimental work on the RPC demonstrated the ability of this model to increase engagement between
researchers and policymakers, increase policymakers’ value for research evidence, and improve their use of
scientific evidence in their policymaking.1 We propose a state-level randomized controlled trial of the RPC (N =
30 state legislatures) that will evaluate the model’s ability to improve engagement between state policymakers’
and the prevention science community, build policymakers’ awareness and value of substance misuse
prevention research, and subsequently their use of research evidence throughout the policymaking process. To
accomplish this, we will test three specific research aims. Aim 1 will assess historical and current use of research
evidence in state legislation pertaining to substance misuse prevention. This will involve qualitative coding of
bills introduced by state legislatures over the last five years. Aim 2 will compare the frequency and quality of
engagement with prevention researchers between the intervention and control conditions. Additionally, we will
assess how the RPC model influences policymakers’ value and awareness of substance misuse prevention over
time using a validated survey across three time points. Aim 3 will evaluate the effectiveness of the RPC on
legislators’ actual use of research in legislation by observing and quantifying changes in legislator behavior
related to research use. Improving the use of scientific information in policymaking can reduce population-level
substance misuse by increasing the availability of evidence-based prevention programs and policies.

Public health relevance
Project Narrative If science is to inform effective substance misuse prevention policy and ultimately improve public health, the field needs an effective strategy for directly supporting policymakers’ use of research evidence, yet our field lacks an evidence-based model designed for this purpose. Accordingly, we propose a state-level randomized controlled trial (N = 30 state legislatures) of a formal, theory-based approach for supporting policymakers’ use of scientific evidence that does not involve lobbying—the Research-to-Policy Collaboration (RPC) Model. This work can reduce population-level substance misuse by improving the use of scientific information in policymaking, thus increasing the availability of evidence-based prevention programs and policies.